Developing a new chordate model for stem cell biology and regeneration

ABSTRACT
The goal of this grant is to adapt contemporary single cell resolution and genomic manipulation
tools to utilize the unique regenerative biology of the colonial ascidian species, Botryllus
schlosseri. The FOA we are responding to from ORIP has as its stated goal to create new and
innovative models for stem cell biology and regeneration, and Botryllus has a proven track
record of innovative studies and a wealth of biology that will be made accessible with these new
tools. Ascidians are chordates, and considered to be the closest living relatives to the
vertebrates. Species such as Ciona have become powerful models in dissecting early steps in
chordate embryogenesis due to their relative simplicity and rapid development, and share many
chordate-specific features, including early mechanisms underlying cell specification, as well as
clonal origins of multiple tissues. In addition to this close phylogenetic relationship, a subset of
ascidian species are colonial, and grow, not by increasing in size, but via a process of
regeneration- whereby entire bodies- including all cardiovascular, nervous, endocrine and
germline tissues- are regenerated, and in Botryllus this occurs every week in a synchronized
fashion, providing a novel model to study regeneration of all major organ systems in a chordate.
Colonial ascidians are the only chordates with the ability to regenerate every tissue and organ in
their body and unique life history characteristics make Botryllus a potentially outstanding model
for these studies.

Public health relevance
We are studying a novel model organism that is closely related to vertebrates and has the ability to regenerate all tissues and organs in its body on a weekly basis, including the GI tract, heart, nervous system and gametes. Other life history characteristics of this organism allow us to study these regenerative processes in a live animal in real time, as well as isolate and transplant the stem cells responsible. We are focused on building contemporary tools which will allow us to study the processes unique to regeneration at high resolution.